Immune Tolerance Network-NIDDK 2024 Supplement

Project Summary / ABSTRACT
The mission of the ITN is to advance the clinical application of immune tolerance by performing
high quality clinical trials of emerging therapeutics based upon testable mechanistic hypotheses.
The ITN is structured in order to interrogate different diseases across the immunologic
spectrum, with integration of innovative clinical studies and cutting edge immunology laboratory
analysis. The ITN approach—clinical assessment of novel tolerance therapeutics, while we
simultaneously evaluate the cellular, genetic, and immunologic mechanisms of disease and how
they are altered in response to therapy—creates a framework for advancing cross-disease and
cross-discipline knowledge, all designed to accelerate therapeutic options for major diseases.
Since its inception, one of the areas of interest of the ITN has been Type 1 Diabetes (T1D) with
a focus to successfully enhance the development of tolerance therapies. We outline a process
to evolve our current strategies into the next generation of planned trials, as well as how we
plan to operate a nimble, future-focused organization, poised to lead and adopt innovations that
are currently unknown. We utilize a collaborative structure involving hundreds of investigators,
advisors, and clinical sites and mechanistic laboratories working in tandem with a core group of
ITN staff, operating a program that is both scientifically and financially efficient. With lead
institutional commitment from the Benaroya Research Institute and the University of California
San Francisco, and participation of more than 20 other major institutions represented in
leadership and major advisory roles, the ITN strives to continue to successfully pioneer high
impact clinical trials and mechanistic studies in T1D.

Public health relevance
Project Narrative The proposed ITN UM1 funding addresses major unmet health needs. In the United States, autoimmune diseases, including T1D, affect >5% of the population. Pre-clinical studies show that immune tolerance should be an achievable therapeutic prospect, and progress towards that goal is evident in recent clinical trials and the resulting mechanistic work. Successful tolerance offers long-term freedom from immunosuppressive therapy, radically improving quality of life, disease burden, and health care costs. 1 Abstract